Application of N-Oxides for the Synthesis of Nitrogen Heterocycles

Project Summary:
Nitrogen heterocycles are a ubiquitous and key structural motif of bioactive natural products and
pharmaceuticals with proven efficacy targeting cancer, psychiatric disorders, antimicrobials, and analgesics.
However, the synthetic strategy of introducing new nitrogen heterocycles into a pharmaceutical framework is
nontrivial and costly, especially when considering complex three-dimensional (3D) targets. We intend to
expand upon our recent body of work that has identified N-oxide chemistry as a promising, innovative,
adaptable solution for this conundrum. To create nitrogen heterocycles of pharmacological interest, we will use
N-oxides, easily prepared and stable compounds, as precursors for [3+2] cycloadditions. N-oxide compounds
were first used in a limited number of cycloaddition reactions in the 1980s. However, despite solid and logical
reasoning at that time, the lack of mechanistic understanding on how these reactions occurred predicted
electrophilic intermediates that would cause side reactions, low yields, and poor stereochemical control.
Consequently, the synthetic community undervalued this reaction manifold and avoided such an approach.
However, re-evaluation of the original experimental data with the perspective of high-quality density functional
theory, led to us uncovering mechanistic details defining the critical role of solvent in such ionic systems, and
eradicated the previously conceived synthetic barriers to efficient use. We intend to resurrect and establish this
unexplored synthetic avenue forming nitrogen heterocycles from simple precursors without onerous overhead
as a practical and significant protocol in medicinal chemistry. Beyond our proposed work delivering key
analgesics (aza-bicycles), novel antimicrobials (imidazolines), and enantio-enriched systems, the impact of N-
oxide chemistry has the potential for many new directions and discoveries including cyclic N-oxides, silyl
imines, and N-chiral compounds. Aligned with NIH/R15 goals, this project has been designed to be
approachable for students of all levels of experience in experimental and/or computational chemistry, adapting
the educational philosophy of Universal Design. Initial experimental projects range from performing and
optimizing established reactions under supervision (beginner) to running novel reactions and analyzing
complex reaction mixtures (advanced/graduate). Likewise, on the computational side students can learn to
build Z-matrixes and identify ground states for new analogs (beginner), progress to finding transition structures,
performing energy decomposition analyses and develop critical analysis skills (advanced/graduate). Ultimately,
our plan is to optimize this N-oxide chemistry to create nitrogen heterocycles as the core component for
analgesics (Aim I), antimicrobials (Aim II), and stereo-defined 3D structures (Aim III). This proposal offers an
innovative, adaptable strategy for creating a wide range of such compounds through a shared reaction
pathway that will empower the pharmaceutical community to expand upon its efforts significantly in the
discovery of novel drugs in the strategic areas of antimicrobials and analgesics.

Public health relevance
Project Narrative: This is a detailed study on how N-oxide chemistry, largely ignored by the synthetic community, can form a wide variety of pharmaceutically significant nitrogen heterocycles, a class of molecules with potent bioactivity including those acting as analgesics and antimicrobials. Leveraging a synergistic mix of experimental and computational chemistry techniques, we maximize our chances of successfully achieving our aims of creating a general, efficient and adaptable synthetic protocol for creating sought after pharmaceutical targets. As we move towards our declared targets, we will increase our understanding of the capabilities of this chemistry, laying the groundwork for future discovery and training students.